GI HORMONES IN CHILDREN WITH CHRONIC PSEUDOOBSTRUCTION

To evaluate the role of gastrointestinal hormones in intestinal pseudoobstruction. Cholecystokinin, vasoactive intestinal peptides and somatostatin will be measured in blood from patients with pseudoobstruction and from age matched controls.